Regulation of cortical neuron migration

DESCRIPTION (provided by applicant): Tyrosine kinases control cell proliferation, differentiation, migration and survival, and are often deregulated in cancer. We are investigating Src proto-oncogene dependent cell migrations during mammalian development. Our past results showed that a Src-dependent signaling mechanism regulates the precise positioning and layering of cells in the developing mouse brain. Our more recent results provide evidence for a Src signaling event that increases membrane-localized N-cadherin on randomly-moving multipolar neurons in the neocortex. N-cadherin then enables directional cell migration. We also discovered the importance of tyrosine phosphorylation-dependent protein turnover in terminating neuron migrations in the cortex, and extended this finding to show that a similar process inhibits Src-dependent tumorigenesis. Therefore we propose to investigate three innovative hypotheses: (1) That a secreted signaling molecule, Reelin, increases surface N- cadherin levels by altering traffic (endo-/exocytosis) or inducing stabilization of surface N-cadherin. (2) That multipolar cells interpret direction signals from the environment through N-cadherin itself or through a cadherin- associated co-receptor. The direction signal may be conveyed by cell-cell contact or by a diffusible signal. (3) That the final positions of cortical neurons are determined by the timely cessation of Reelin-dependent terminal translocation, which stops when Cullin5-dependent mechanisms destroy the Src substrate, Dab1. Progress in these Aims will reveal molecular mechanisms underlying complex cell migrations in vivo. PUBLIC HEALTH RELEVANCE: Src kinases are tightly regulated enzymes that normally control development of the embryo and homeostasis of the adult, yet Src de-regulation leads to cancer. This proposal will investigate a key developmental function of Src in controlling the movements of immature neurons in the brain during development. Past research led to the discovery of a pathway that inhibits Src during development and also in cancer. The future aims address other new aspects of cell biology discovered in the brain development system.

Public health relevance
Src kinases are tightly regulated enzymes that normally control development of the embryo and homeostasis of the adult, yet Src de-regulation leads to cancer. This proposal will investigate a key developmental function of Src in controlling the movements of immature neurons in the brain during development. Past research led to the discovery of a pathway that inhibits Src during development and also in cancer. The future aims address other new aspects of cell biology discovered in the brain development system.